SD INBRE Administrative Supplement Extension

SD INBRE Project Summary
The South Dakota IDeA Network of Biomedical Research Excellence (SD INBRE) is hosted by the Sanford
School of Medicine of the University of South Dakota (USD), in Vermillion, SD. This is the SD component of
the INBRE program, and it has been funded by the NIH/NIGMS since 2001. The goal of SD INBRE is to
maintain and grow the biomedical research infrastructure within the state of South Dakota. To accomplish this,
we will expand research capacity in SD in the area of cell biology and the control of cell and microbial growth.
Cell biology is broadly defined for the purposes of SD INBRE, and our students and faculty will evaluate the
molecular interactions that both influence a cellular response and are produced after a cell is stimulated. We
will align core resources to increase the use of equipment, personnel, funding opportunities, and reporting
infrastructure as we maximize research productivity across SD INBRE. Our plans to enhance SD INBRE
faculty development in scholarship, grantsmanship, and mentorship will allow faculty at partner institutions to
gain research support and mentoring as they increase publications and grant submissions. We will provide
research opportunities for SD INBRE undergraduate students to receive training in biomedical sciences at
partner institutions throughout SD. These research experiences will include both summer and academic year
opportunities. Our plans for outreach include providing K-20 students with examples of how biomedical
research can help them achieve their career goals. We will use our small population of scientists to engage
researchers across all career stages at our partner institutions. Together, we will accomplish our goal by
providing SD students and faculty with a unique infrastructure that will advance biomedical research across our
state. Over the past two decades, SD INBRE has established a culture of biomedical research across South
Dakota. The core resources and research opportunities have expanded training and mentoring of students and
faculty across our network. We will build on these successes as we use our unique infrastructure to align
faculty, equipment, and personnel across SD INBRE.

Public health relevance
SD INBRE Project Narrative The goal of South Dakota IDeA Network of Biomedical Research Excellence (SD INBRE) is to maintain and grow the biomedical research infrastructure within the state of South Dakota. We will accomplish this goal by expanding research capacity in SD in the area of cell biology and the control of cell and microbial growth, aligning core resources with SD INBRE investigators, and enhancing SD INBRE faculty development in scholarship, grantsmanship, and mentorship. SD INBRE will provide research opportunities for undergraduate students at partner institutions, use outreach programs to engage students in research opportunities, and align members across career stages by providing unique collaborations and learning environments.